Next Generation Sequencing Core

Summary
Core C: Next Generation Sequencing core (NGSC)
The next generation sequencing core (NGSC) will be responsible for all next generation sequencing activities
by the four projects. All sequencing activities will be performed in Core C. RNA-Seq, ChIP-Seq, ATAC-Seq,
Core C will be responsible for 1) performing NGS-assays; 2) generating library for Illumina next-generation
sequencing, 3) mapping sequence data to EBV, KSHV, MPyV and human genomes, and 4) providing all
follow-up bioinformatics and biostatistics analyses for the overall program. These goals will be accomplished in
conjunction with the Penn Genomics, Next-Gen-Sequencing and Bioinformatics Cores, which provides Illumina
Next Generation Sequencing as a core service. Final data management and analyses will be made accessible
to each project investigator via a password protected shared web-based browser for program investigators.
Expertise in all aspects of Next-Gen-Sequencing (NGS), Chromatin immunoprecipitation, and Bioinformatics
support will be provided to the projects for the lifetime of the award. The NGS core will be led by experience
leaders in administration and technical expertise to ensure that the core will be successful. Dr. Lieberman, is
an expert in NGS and is familiar with all aspects of NGS technologies. Dr. Robertson has led many large
complex programs, and is familiar with management and coordination of the technical expertise needed for
success. Thus, the leadership is familiar with different NGS methodologies and bioinformatics analyses as
applied to oncogenic herpesviruses and the human genome. Core C leaders have both provide unique
expertise that complement each other. The NGS Core C will facilitate the ability of all members of the Program
to standardize methods for sample preparation and for post-sequence bioinformatics analyses. The work will
be performed at the Perelman School of Medicine in space adjacent to the Robertson lab, and in conjunction
with the Penn Genomics NGS Core, and Bioinformatics core supported in part by the Abramson Cancer
Center.

Public health relevance
Narrative: The Next Generation Sequencing core (NGSC) is responsible for all high-throughput sequencing and bioinformatics activities required for DNA, RNA and ChIP-sequencing. All activities including library preparations will be done at the NGSC and will be done closely connected with the ACC NGS Core facility supported by the NCI Abramson Cancer Center.